The Stanford-SLAC CryoEM Center

Summary
Stanford University and the SLAC National Accelerator Laboratory propose to continue the
Stanford-SLAC CryoEM Center (S2C2) as a National Center for Cryogenic Electron Microscopy
to meet the growing demand for atomic-resolution structural biology. S2C2 will 1) upgrade and
maintain six cutting-edge cryo-electron microscopes, 2) record and archive image data with
comprehensive metadata, 3) assist users to overcome technical challenges in preparing vitrified
samples suitable for high-resolution cryoEM structure determination and in data acquisition, 4)
provide real-time data quality assessment, 5) ensure public accessibility of our resources
regardless of user’s geographical location, 6) select user proposals based on scientific impact
and readiness as judged by external experts’ evaluations, 7) disseminate cryoEM best practices
through seminars, workshops, and user meetings, 8) train independent cryoEM researchers, 9)
integrate and evaluate user feedback for facility improvement, 10) implement and validate new
instrument and technology as developed , and 11) optimize center operational efficiency. Led by
Dr. Wah Chiu, Dr. Michael Schmid and Dr. Britt Hedman, supported by an Advisory Committee
comprising external expert scientists and user representatives, and leveraging SLAC's many
decades of expertise in serving a wide range of scientific users, including those from IDeA states
and under-resourced institutions, S2C2 will foster high-throughput cryoEM data generation,
optimization of vitrified sample preparation, and cross-disciplinary training for novice and
advanced users. Our collective efforts will shape the future of cryoEM structural biology, enabling
unprecedented discoveries crucial to fundamental biomedical sciences.

Public health relevance
Narrative Statement Stanford University and the SLAC National Accelerator Laboratory propose to operate a National Cryogenic Electron Microscopy (cryoEM) Center, providing free access to state-of-the-art instruments for atomic resolution structure determination in foundational biology and human health research. Additionally, the Center will focus on optimizing the vitrification process for high- resolution data collection from biochemically purified samples. Through a comprehensive training program, we aim to empower scientists from diverse institutions, fostering their independence as cryoEM investigators and disseminating cryoEM technology to traditionally under-resourced research institutions.